IMAAP: Development and evaluation of an Interactive Mobile Asthma Action Plan

Project Summary
This project will include the development and evaluation of IMAAP, an Interactive Mobile Asthma Action Plan
to support asthma self-management and adherence to ‘as needed’ rescue medications, which are a critical
component of preventing exacerbations. The burden of asthma continues to fall disproportionately on
historically marginalized populations (i.e., individuals experiencing social determinant of health [SDOH]-related
challenges such as racism and discrimination, difficulties accessing healthcare, financial instability, and limited
social support). An innovative tool that presents a patients’ physician-prescribed Asthma Action Plan
recommendations in a way that all youth can understand is needed to improve access to care and the quality
of asthma care, decrease disparities, and promote health equity. IMAAP will be an innovative, easy-to-use
technology that leverages objective assessment of lung function (mobile spirometry), quantitative symptom
report, and an individualized AAP to provide personalized, real-time treatment recommendation decision
support to empower adolescents to improve their health. With this project, IMAAP will first be iteratively
developed through discovery interviews and feedback from adolescents from marginalized populations, their
caregivers, and health care providers. Discovery interviews with health care providers, specifically, will be used
to develop an innovative algorithm that will map asthma symptom and lung function presentations to patients’
individualized Asthma Action Plans. Prototype testing will be completed to ensure the safety of patients using
IMAAP and to expeditiously obtain user feedback from patients and caregivers in a variety of situations prior to
going live. Finally, a Phase IIb pilot randomized controlled trial will be conducted to compare a sample of 20
adolescents with moderate to severe persistent asthma (ages 12-18) using IMAAP to 20 adolescents in a
treatment as usual group. All adolescents in the development and RCT phases will have ≥1 SDOH-related
challenge. The primary outcome for this trial will be feasibility of IMAAP. Feasibility will be assessed by comparing
rates of participation, engagement, enrollment, retention, and reach to a priori criteria. User acceptability and
usability will also be assessed as secondary outcomes, as well as electronic monitored rescue medication
adherence and health outcomes. As an exploratory aim, we will examine social determinants of health as predictors
of feasibility and health outcomes. Results will lead to further refinements and an adapted version of IMAAP ready
for full-scale efficacy testing in a future trial.

Public health relevance
Project Narrative Asthma disproportionately impacts youth who have been systematically marginalized. The purpose of this study is to develop and evaluate an Interactive Mobile Asthma Action Plan (IMAAP) to support asthma self- management and adherence to ‘as needed’ rescue medications, which are a critical component of preventing exacerbations. If successful, IMAAP has long-term potential in preventing exacerbations, improving health outcomes, and promoting health equity particularly for adolescents with asthma from marginalized populations.